ALCOHOLISM RESEARCH COLLECTION, ANALYSIS, DISSEM (ARCAD)

The Alcohol Research Collection, Analysis, and Dissemination (ARCAD) project provides support to the Scientific Communications Branch in the following areas: * maintaining and updating the Alcohol and Alcohol Problems Science Database publicly through an online vendor. * maintaining and updating the Alcohol and Other Drug Thesaurus. * maintaining the Institute's alcohol research library. * producing a variety of publications, including the Institute's quarterly journal, Alcohol Health & Research World; the quarterly bulletin, Alcohol Alert, monographs, booklets, and other types of publications. * providing graphics support. * maintaining and developing scientific exhibits. * staffing and handling logistics for up to 20 professional meetings annually at which Institute exhibits are displayed and ETOH is demonstrated. * handling arrangements for three meetings annually of various advisory boards that assist the Institute with its products and services * assisting with developing, purchasing, maintaining and updating mailing lists, warehouse tasks, and distribution tasks.